A Placebo Controlled Trial of L-Tryptophan in Post-Operative Delirium

DESCRIPTION (provided by applicant): CANDIDATE- Dr. Thomas Robinson, MD is an Associate Professor of Surgery at the University of Colorado at Denver (UCD). Dr. Robinson has a strong background in both aging related research (studying post-operative delirium) and education (teaching surgeons geriatric specialty knowledge). Dr. Robinson's immediate career goals are to learn the skills necessary to perform exceptional aging-related translational research in the field of surgery. Dr. Robinson's long term career goals are to become an independent translational researcher with a focus on studying post-operative delirium in elderly patients, and to become a national champion of geriatrics research and education within the field of surgery. RESEARCH PROJECT- Post-operative delirium is a common, deleterious complication in elderly patients. This double-blinded, placebo controlled trial (including subjects 60 years and older following a major operation requiring surgical ICU admission) will randomize patients to receive L-tryptophan supplementation or placebo with the primary outcome measure being the incidence and/or duration of excitatory (both hyperactive and mixed) post-operative delirium. Delirium will be assessed twice daily post-operatively. Biomarkers (tryptophan, serotonin and melatonin) will be measured pre- and post-operatively. We hypothesize that the incidence and/or duration of excitatory (both hyperactive and mixed) post-operative delirium will be reduced in the group receiving L-tryptophan supplementation compared to placebo. CAREER DEVELOPMENT- The three main areas of Dr. Robinson's career development plan includes clinical research knowledge, geriatric specialty care knowledge and neuropsychology knowledge. At the end of the career development training, Dr. Robinson will be a surgeon who has acquired the skills of a translational research, and who understands fundamentals in geriatrics and the neurosciences. ENVIRONMENT- The environment at UCD is ideal for allowing an enthusiastic young surgeon to acquire expertise and to perform surgical aging-related translational research. The Department of Surgery resolutely supports Dr. Robinson's research and career development efforts. Dr. Robinson has established close and productive mentor-mentee relationships over the past two years with his primary co-mentors. The Denver VA supports enrollment of geriatric surgical patients for the proposed study.

Public health relevance
PUBLIC HEALTH RELEVANCE: In the United States, 55% of all operations performed are in patients older than 65 years and delirium is the most common post-operative complication in elderly patients. The goal of this research endeavor is to reduce post-operative delirium in elderly individuals who undergo major operations. If successful, this study could have profound implications for the care of millions of elderly patients undergoing operations annually. Project Narrative In the United States, 55% of all operations performed are in patients older than 65 years and delirium is the most common post-operative complication in elderly patients. The goal of this research endeavor is to reduce post-operative delirium in elderly individuals who undergo major operations. If successful, this study could have profound implications for the care of millions of elderly patients undergoing operations annually. __SpecificAimsTextDelimiter__ 10. Specific Aims - A Placebo Controlled Trial of L-Tryptophan in Post-Operative Delirium Background: Post-operative delirium is a common and deleterious complication in older patients.5 Neurotransmitter alterations within the central nervous system almost certainly play an important primary role in the final pathway of delirium.6 Tryptophan is an amino acid precursor to the delirium-relevant neurotransmitters serotonin and melatonin.7 Tryptophan supplementation creates hypnosis;8,9 an effect attributed to increased levels of serotonin10 and melatonin.11 Ultimately, it may be the ratio of these neurotransmitters which is important to the pathophysiology of delirium and not their absolute values. Therefore, replacing tryptophan (the primary substrate) rather than its end-products is advantageous by allowing intact downstream physiologic counter-regulatory mechanisms to determine the appropriate subsequent neurotransmitter levels and/or ratios. Tryptophan homeostasis is well described to be disrupted in the post-operative setting.12,13 Our work,1 in addition to that of others,13,14 found lower post-operative levels of tryptophan in patients who develop delirium. Because the major pathway for tryptophan metabolism leads to accumulation of sedating neurotransmitters; we hypothesize that the low levels of tryptophan associated with post-operative delirium may be more closely related to the excitatory (both hyperactive and mixed) delirium motor subtype. Consequently, we hypothesize that supplementation with oral tryptophan post-operatively will reduce the excitatory (both hyperactive and mixed) delirium motor subtype. Hypothesis 1a: The incidence and/or duration of excitatory (hyperactive and mixed) post-operative delirium, diagnosed by the Confusion Assessment Method-ICU (CAM-ICU) with the Richmond Agitation Sedation Score (RASS), will be reduced with enteral L-tryptophan supplementation (1 gm TID for the first 3 post-op days), compared to placebo, in older patients (e 60 years) undergoing operations requiring ICU admission. (FIG 1) Hypothesis 1b: The incidence and/or duration of all types of post-operative delirium, diagnosed by the CAM- ICU with the RASS, will be reduced with enteral L-tryptophan supplementation (1 gm TID for the first 3 post-op days), compared to placebo, in older patients (e 60 years) undergoing operations requiring ICU admission. Hypothesis 2: Post-operative tryptophan, serotonin and melatonin will all be higher in the supplemented group compared to those receiving placebo, and the level of one or more of these (or ratios between them) will be inversely related to the incidence and/or duration of excitatory and/or overall post-operative delirium. Hypothesis 3 (secondary): Outcomes (length of stay, hospital mortality, post-discharge institutionalization, six-month mortality and six-month functional status) will be improved in the supplemented group compared to placebo and that this improvement will be related to the reduction in incidence/duration of delirium. Study Design: This is a double-blinded, placebo-controlled trial. The study has already received an FDA IND and has been fully approved by the University of Colorado Denver IRB and we have enrolled 62 subjects. Subjects- Patients 60 years and older, who are undergoing a major elective operation requiring admission to the surgical intensive care unit will be recruited. Baseline (pre-op) evaluation- Cognition, function, depression and co-morbidities will be determined. Intervention- Subjects will be randomized to receive either L-tryptophan 1 gram enterally TID or similar appearing placebo daily for three days following their operation. Outcome measures- o Delirium and its motor subtypes will be assessed twice daily during the entire post-operative hospital stay with the CAM-ICU (RASS scores will be used to determine motor subtype) by a blinded researcher. o Levels of tryptophan, serotonin and melatonin will be determined pre-op and on post-op day 2. o Other post-operative outcomes will include: length of stay, hospital mortality, post-discharge institutionalization, six-month mortality and six-month functional status. Specific Aims: (1a) Compare the incidence and duration of post-operative excitatory (hyperactive and mixed) delirium in the group that receives L-tryptophan compared to placebo. (1b) Compare the overall incidence and duration of post-operative delirium in the group that receives L- tryptophan compared to placebo. (2) Compare pre- and post-operative levels of serum tryptophan, serotonin and melatonin in the group that receives L-tryptophan compared to placebo. (3) Compare the outcomes of length of stay, hospital mortality, post-discharge institutionalization, six-month mortality and six-month functional status in the group that receives L-tryptophan compared to placebo. Significance: The ultimate goal of this research is to elucidate treatments to reduce post-operative delirium in elderly individuals who undergo major operations. If successful, this study could have profound implications for the peri-operative care and outcomes of millions of elderly patients undergoing operations annually.